NRSA Training Core

CORE J. TL1 TRAINING PROGRAM – PROJECT SUMMARY/ABSTRACT
The University of Rochester Clinical and Translational Research Institute (UR CTSI) TL1 NRSA Training Core
aims to produce innovative, cross-trained, experienced researchers who contribute to the rapidly evolving and
shifting needs of the US clinical and translational research workforce. Our long-term model of training graduate
students, year-out medical students, and postdoctoral fellows across the translational science spectrum has
adapted to shifting opportunities and discoveries in science, trends in educational strategies and skills, and
serves the University's distinct multicultural, geographic, and multidisciplinary needs. We focus on immersion in
mentored research training and experience at multiple levels of the training pipeline to engage communities not
traditionally represented among researchers, and to provide formal degree credentials through innovative
programming. Leveraging the strengths of our institution, we aim to promote exposure and opportunities in the
focus areas of our parent CTSA award, in particular toward: 1) building a culture of data excellence supporting
extensive data integration, and 2) extending our Learning Health System to improve population health by taking
clinical and translational research beyond the walls of academia. We accomplish our goals by: 1) offering a
comprehensive, wrap-around, multi-leveled learning/experiential environment, 2) offering the opportunity for
completion of innovative credentials to promote a career in clinical and translational science, and 3) immersion
in stage-appropriate, mentored clinical/ translational research that connects populations, data, and innovations.
We expand on our previous innovative strategies and programs that have been successful in recruiting
underrepresented populations into our clinical research training program, which is a hallmark of the TL1. Our
specific aims are as follows: Aim 1: Contribute to a diverse, well-trained clinical research workforce by recruiting,
mentoring, and immersing students into a focused set of training opportunities across the translational research
spectrum. Aim 2: Create a heterogeneous Trainee pipeline and stimulate interest in clinical research training
and career paths by engaging priority populations (1: Deaf Trainees; 2: Underrepresented Communities; and, 3:
Undergraduate students) in short-term immersive research exposures. Aim 3: Engage alumni working in a
variety of sectors and industries to promote exploration of translational training and careers within and outside
of academia. Aim 4: Harmonize the TL1 Program with the Administrative Core's Evaluation Working Group to
ensure continuous program improvement using multiple metrics to review, revise and improve training strategies
and quality as well as best practices and mentor training and evaluation. The TL1 program closely aligns
governance with the KL2 program and integrates with the Hub's Translational Workforce Development Function,
aiming to create and enhance a contemporary, flexible, multi-skilled base of researchers and contributors to the
clinical research enterprise with practical experience across disciplines and beyond the walls of academia.